The IDeA State Consortium for a Clinical Research Resource Center: Increasing Clinical Trials in IDeA States through Communication of Opportunities, Effective Marketing, and WorkforceDevelopment

A recent analysis demonstrated that approximately 10% of NIH sponsored clinical trials were being conducted
in Institutional Development Award (IDeA) states. Though reasons for underrepresentation in clinical trials are
likely multifactorial, accessibility to trials in IDeA states is an important limitation. The IDeA State Consortium for
Clinical Research Resource Center (ISCORE-RC) was launched in the fourth quarter of 2023 to increase clinical
trials in IDeA states through establishment of a service center to highlight trial opportunities and a clinical
research coordinator (CRC) training program to address workforce needs. Stakeholder buy-in of the current
ISCORE-RC Charter Members (35 CRC program applicants from eight charter sites) and interest from additional
sites necessitates the need for additional funding and program expansion. This supplemental application will
provide for ISCORE-RC services to additional sites, including the new cohort of IDeA-CTR-Ds and healthcare
organizations not affiliated with IDeA-CTRs. We will also develop and implement an advanced certificate
curriculum with both didactic and experiential components focused on clinical trials in pediatric populations.
Unique considerations for pediatric populations require specialization and additional training3. Partnering with
the IDeA States Pediatric Clinical Trials Network (IPCTN), ISCORE-RC will develop optional specialized training
for research professionals conducting clinical trials among pediatric populations.

Public health relevance
The overall goal of this project is to increase numbers of clinical trials and observational cohort studies in Institutional Development Award (IDeA) states that currently have less than 10% of active NIH supported trials. Strategies to accomplish this goal include communicating to trial sponsors the expertise, quality, and capacity of IDeA state institutions to conduct clinical trials and to IDeA investigators available clinical trial opportunities. We will also train a cadre of skilled research coordinators across IDeA states to provide the necessary workforce capacity to conduct increased numbers of trials.